Tau-induced astrocyte senescence in Alzheimer's disease

Contact PD/PI: Galvan, Veronica
ABSTRACT
Health and function of the nervous system relies on astrocytes, the most abundant glial cell in the mammalian
brain. Astrocytes are integral components of brain architecture, and critically regulate brain function and
plasticity through dynamic interactions with synapses. Accumulation of abnormally phosphorylated tau protein
in astrocytes is common in aging and is exacerbated in Alzheimer's disease (AD). In AD, hyper-phosphorylated
tau in neurons detaches from microtubules to form soluble aggregates, destabilizing the microtubule
cytoskeleton. Pathogenic soluble tau aggregates (also called tau oligomers) are then released and transfer trans-
neuronally, promoting tau aggregation and destabilization of the microtubule cytoskeleton in target cells.
Aging contributes the largest biological risk for AD; yet the mechanisms that link aging to AD remain elusive. The
development of cellular senescence and the accumulation of senescent cells during aging compromises tissue
function. Senescent astrocytes accumulate in AD brain. We discovered that, similar to trans-neuronal
propagation, soluble pathogenic tau aggregates are transmitted to astrocytes, where they potently trigger
microtubule destabilization and cellular senescence. The functional impact of tau transmission to astrocytes, and
its contribution to AD, however, remain unexplored. Our central hypotheses are that: (a) tau-induced astrocyte
senescence is a key driver of neuronal dysfunction and cognitive decline in AD, and (b) removal of pathogenic
tau or senescent astrocytes will treat AD-related dysfunction in a surrogate model of AD by restoring neuronal
function. We propose two Specific Aims. Aim 1 will define how tau transmission causes astrocyte senescence,
and will identify heterogeneous subtypes of senescent astrocytes and their secreted factors in a surrogate
model of AD tauopathy; Aim 2 will (a) establish the therapeutic potential of pathogenic tau or senescent cell
removal in AD-related neuronal and cognitive dysfunction, (b) determine, in human brains, how accumulation of
astrocyte tau and of senescent astrocytes is linked to molecular abnormalities identified in Aim 1 during AD
progression; and (c) define the incidence of heterogeneous subtypes of senescent astrocytes identified in Aim 1
in human AD. This work will address, for the first time, the involvement of tau-induced astrocyte senescence in
AD etiology, and will markedly advance knowledge of how pathogenic tau (and the cellular events it triggers) and
senescence itself can be targeted therapeutically. By singling out astrocyte senescence as a novel mechanism
of AD-like pathogenesis in mice, we will open up a completely new avenue of investigation in AD.
Because tau immunotherapy is being advanced in the clinic and the senolytics we will use are FDA-approved,
our results could have rapid translational potential, contributing new and urgently needed tools to treat AD and
potentially other dementias.
Project Summary/Abstract Page 7

Public health relevance
Accumulation of cells undergoing senescence during aging compromises tissue function; astrocytes, critical for brain function, display markers of senescence in Alzheimer’s disease (AD). We discovered that pathogenic tau protein causally implicated in AD potently induces senescence by its transmission to astrocytes. By defining the role of pathogenic tau-induced astrocyte senescence in AD we will open up a completely new avenue of investigation that will contribute urgently needed tools to treat AD and potentially other dementias.